Platelets promote growth of ovarian cancer

Project Summary/Abstract
Elevated platelet counts are detected in about 30% of ovarian cancer patients and associated with a poor
prognosis. We found that thrombocytosis in ovarian cancer is not just epiphenomena of an advanced
malignancy, but in fact, platelets promote tumor growth. By reducing platelet counts, we reduced the growth of
primary tumors in murine models of ovarian cancer. While most of the previous studies focused on the role of
platelets in promoting metastasis, we discovered that platelets increase the growth of primary tumors by
enhancing proliferation of cancer cells. The basis for the effect of platelets on tumor growth is the interactions
between platelets and cancer cells. We found that ovarian cancer cells activate platelets by secreting ADP, and
activated platelets secrete Tgfβ1 that promotes cancer cell proliferation. Blocking or deficiency of P2Y12 ADP
receptors on platelets, blocking or deficiency of Tgfβ1 in platelets, or reducing Tgfβ1 receptor 1 (TgfβR1) on
cancer cells reduced the pro-growth effects of platelets on ovarian cancer. During studies on ovarian cancer
tumors resected from patients and tumor-bearing mice, we observed extravascular platelets inside tumors. We
propose that the main effects of platelets on cancer are mediated by extravasated platelets. Migration of platelets
outside of blood vessels is not a well-known phenomenon, despite the fact that platelets possess the molecular
machinery required for extravasation, and are able to undergo drastic structural changes necessary for
extravasation of neutrophils that are professional migratory cells. Our in vivo and in-vitro studies on platelet
extravasation into tumors showed that this process is an active process and is reduced by antiplatelet agents
(aspirin or ticagrelor). In the first aim of this proposal, we will study the stimuli from tumors that initiate platelet
extravasation. We will identify the molecular mechanism of transendothelial migration of platelets, and
investigate the facilitatory effects of pericytes on platelets extravasation. After exiting blood vessels, platelets
become activated by cancer cells and tumor stroma. In the second aim of this proposal, we will investigate the
mechanism of platelet activation in the cancer by dissecting the role of various G-protein-coupled receptors on
platelets in tumor growth. We will study the redundancy, synergism, or opposing effects of different platelet G-
proteins on platelet-cancer cell interactions. In the third aim, we will investigate the correlation between our
findings in the murine models of ovarian cancer and the behavior of ovarian cancer in patients. We have used
advanced imaging studies to accurately and objectively quantify platelet density in tumor tissues. We will
determine platelet density in tumor specimens resected from 60 patients diagnosed with ovarian cancer in M.D.
Anderson Cancer Center (from a pool of 485 patients recruited to the Ovarian Cancer Moon Shots program in
our institution). We will correlate platelet density inside tumors with the response rate to surgery, chemotherapy,
and antiangiogenic therapy and the survival rates; and determine whether platelet density can be used as a
predictive marker for the response rates to therapy and as a prognostic marker for survival and recurrence rates.

Public health relevance
PROJECT NARRATIVE Platelets directly interact with ovarian cancer cells and promote tumor growth. In this project, we will identify the mechanism of platelets' exit from blood vessels to reach cancer cells, and the ways to block it. We will investigate whether the number of platelets inside a tumor would predict the aggressiveness of that tumor.